Multi-Omics Approaches for the Diagnosis and Risk Stratification of Pulmonary Fibrosis-Associated Pulmonary Hypertension

Project Summary
This is an application for a K23 award for Adam J Brownstein, MD, MS, a Pulmonary and Critical Care
physician at the University of California, Los Angeles. The goal of this proposal is for Dr. Brownstein to
establish himself as independent investigator in patient-oriented research in the field of pulmonary
hypertension, with a focus on pulmonary fibrosis-associated pulmonary hypertension (PF-PH). This K23 award
will provide Dr. Brownstein with the support to (1) develop proficiency with prospective clinical study design for
future multi-institutional studies and clinical trials, (2) develop expertise in the application of multi-omics
approaches to PH detection, risk-stratification, and evaluation for lung transplantation in PF-PH, (3) determine
the feasibility and utility of developing peripheral blood biomarkers that reflect pulmonary vascular disease
severity in PF, (4) become an expert in large data analysis integrating clinical data with omics analyses and
advanced statistical modeling, including machine learning approaches, and (5) become an independent
translational researcher. Dr. Brownstein is supported by an excellent multidisciplinary mentoring team. Dr. Xia
Yang and Dr. Airie Kim, the two primary mentors of this K award, will provide complementary guidance
regarding applying multi-omics approaches and translational research design. Dr. Brownstein will also work
closely with Dr. Rajan Saggar, a leader in the PH field with expertise in clinical trials and observational cohort
studies and Dr. David Elashoff, the leader for the Biostatistics, Epidemiology and Research Design program for
the UCLA CTSI.
PF is often complicated by the development of PH, leading to significantly reduced survival and
increased morbidity. Our preliminary data, which leveraged transcriptomic analysis of explanted lung tissue
from patients with PF, has identified a module of genes (referred to as the “tan” module) as potentially
pathogenic in PF-PH. However, a better understanding of the cell-specific pathways altered in PF-PH is
required to predict those at risk of progressing to clinically significant PF-PH and identify novel therapeutics
and biomarkers of disease. This proposal will investigate the PF-PH lung and blood transcriptome by using
lung and blood samples collected as part of the UCLA PF and PH biorepository, which includes prospectively
collected biospecimens, hemodynamics, echocardiography and other clinical markers of PH. We will also use
the PF Foundation Registry to identify a blood transcriptomic signature of PF-PH using machine learning
approaches. The specific aims are: 1) Define cell-specific transcriptional changes in lung tissue of PF-PH
patients compared to PF-NoPH and PAH, and correlate these findings with clinical markers of disease severity
and 2) Evaluate the blood transcriptomic signature of PF-PH patients in order to identify and develop blood
biomarkers and predictors of disease. The proposed studies will enable Dr. Brownstein to develop into an
independent investigator focusing on PH translational research.

Public health relevance
Project Narrative Pulmonary hypertension (PH) is an incurable disease that often afflicts patients with pulmonary fibrosis (PF), leading to significantly reduced survival and increased morbidity; however, no standardized screening approach for detection of PH in PF or specific biomarker of disease exists. An enhanced understanding of the dysregulated pathways in PF-PH is required to develop novel methods to identify patients with clinically significant PF-PH earlier in the disease course. The proposed studies will utilize multi-omic methods, coupled with machine learning approaches to clinical data analysis, to provide greater insight into PF-PH disease pathogenesis and lay the groundwork for future translational studies that seek to permit earlier diagnosis and personalize clinical risk stratification and management of pulmonary vascular disease in PF.